Abnormal intracellular calcium release in heart failure

ABSTRACT
Heart failure (HF) continuous to be a major health care challenge. Altered myocyte calcium (Ca) signaling is an
essential part of the pathophysiology of HF and of critical relevance in the search for new effective therapies.
Despite progress in the elucidation of Ca-dependent processes occurring on rapid time scales, mechanisms
whereby Ca modulates slow cardiac processes, including long term adaptations to physiological and pathological
stress, remain poorly understood. This critical barrier to progress is attributable to our poor understanding of
foundational aspects of cardiomyocyte biology, including sites and mechanisms of protein synthesis, processing
and delivery. This is compounded by the lack of technological tools for probing and tracking slower / long-lived
molecular process in living myocytes. Store-operated Ca entry (SOCE), wherein depletion of intracellular Ca
stores prompts extracellular Ca entry into the cytosol, has recently emerged as an important component of
cardiomyocyte Ca signaling. SOCE is mediated by the stromal interaction molecule (STIM1), which, upon
sensing sarco/endoplasmic reticulum (SR/ER) Ca depletion, interacts with and activates the sarcolemmal Ca-
release activated channel protein (ORAI1). STIM1 has been reported to play a critical role in maladaptive
hypertrophy. However, the mechanism whereby STIM1 contributes to hypertrophy and its role in adaptive
hypertrophy (exercise-induced) remain to be elucidated. Recently, we discovered that SOCE and its molecular
machinery are localized at the cell-to-cell contact sites, the intercalated discs (IDs). Based on preliminary results,
we put forth a novel hypothesis that SOCE promotes myocyte longitudinal growth through facilitation of localized
protein synthesis from a dedicated pool of mRNAs at the IDs. Indeed, SOCE in the normal heart may be optimally
tuned to achieve a “Goldilocks zone” of adaptive hypertrophic response, as induced by exercise. In contrast,
pathological dysregulation of SOCE may prove deleterious. Specifically, SOCE over-activity in disease may
underlie maladaptive hypertrophy, thus leading to phenomena such as stress-induced cardiomyopathy (SCM).
In this proposal, we will use cutting-edge cellular physiology and molecular techniques (including super-
resolution microscopy, novel cellular reporter systems) and novel genetic mouse models to test these
hypotheses and determine key cellular micro- and nanodomains, as well as molecular steps involved in SOCE-
driven myocyte growth. We will also examine the possibility of targeting key components of the SOCE machinery
(specifically, STIM1L, the long splice variant of STIM1) that mediate maladaptive hypertrophy. To this end, we
propose the following specific aims: 1) Define the role of SOCE in adaptive and maladaptive hypertrophy. 2)
Define subcellular and molecular mechanisms underlying modulation of hypertrophy by SOCE; and 3) Define
the role and mechanism of SOCE in stress-induced hypertrophic cardiac disease. These studies will yield new
insights into the mechanisms underlying physiological and pathological hypertrophy and provide a foundation for
new mechanism-based therapies for abnormal cardiac structure and function.

Public health relevance
PROJECT NARRATIVE During normal physiologic stress (such as endurance exercise training), the heart muscle increases in size (undergoes hypertrophy), but in disease the heart muscle undergoes hypertrophy but later becomes weak (heart failure). We propose to study a process called Store-Operated Calcium Entry (SOCE) in both favorable (physiologic stress due to exercise) and unfavorable forms (resulting in heart failure) of altered heart structure and function. Findings from these studies may be used to find new therapies for heart failure.